Improved clinical and biologic outcome measures in Aicardi Goutieres Syndrome

ABSTRACT
Aicardi Goutières Syndrome (AGS) is a rare genetic disorder of excessive interferon (IFN) production, resulting
in severe, systemic inflammatory injury and potentially profound disabilities. Most individuals affected by AGS
exhibit some degree of neurologic impairment, ranging from mild spastic paraparesis to severe global
developmental delay. Additionally, interferon overexpression results in systemic manifestations and recurrent
aseptic fevers with severe, chronic irritability. AGS therapeutic trials are limited by heterogeneous patient
populations and the lack of disease-specific outcome measures.
In Specific Aim 1, we will characterize clinically distinct AGS subgroups at the time of presentation and assess
correlation with longitudinal history. We anticipate the identification of cohorts based on statistically relevant
disease features that best predict clinical trajectory and outcome.
In Specific Aim 2, we will define a novel AGS rating scale to assess longitudinal change. We hypothesize that
application of a disease-specific clinical rating scale at defined time points will more closely correlate with disease
progression compared to a daily symptom diary and traditional clinical outcome assessment tool results obtained
in Project 1.
In Specific Aim 3, we will explore the proportionality between a prospective biomarker, interferon signaling gene
(ISG) expression, and clinical outcomes.
The expected outcome of these aims is the development of tools for clinical trial readiness in AGS. We will
identify clinically distinct subgroups of AGS, design an AGS-specific clinical rating scale, and explore the
relationship of ISGs to clinical disease. It is expected that the development of these tools will facilitate clinical
trial design, with immediate utilization in this setting.

Public health relevance
PROJECT NARRATIVE Urgent need for clinical trial readiness has been demonstrated by a recent expanded access use pilot study using baricitinib, a JAK inhibitor (NCT01724580; JAGA) in which we demonstrated that current outcome assessment tools do not adequately capture the impact of the disease and the subsequent improvement. In this proposal, we will begin to bridge those gaps by identifying clinically distinct subgroups of AGS, designing an AGS-specific clinical rating scale, and exploring the relationship of a novel biomarker, interferon signaling genes, to clinical disease. It is expected that the development of these tools will facilitate clinical trial design, with immediate utilization in this setting.